Data Management Core

Our group has developed a set of data standards over the years to capture different aspects of immune profiling studies that enable the description of, for example, the immune exposure being studied (e.g. type and course of infection or vaccination) or the molecular markers measured in a cytometry assay and how they relate detected cells to specific cell types. These standards were primarily developed for the Human Immunology Project Consortium (HIPC), and were tailored to be interoperable with the ImmPort submission system, in which they have been adopted and are now used for all data submissions into ImmPort. For HIPC, these standards have enabled cross-center data analysis projects and method development. As part of this work, automated validation routines have been created that test ImmPort data submissions for their adherence to these data standards, which has enabled us to identify and correct issues in data submissions..

Public health relevance
Our proposal for developing IMPACC data standards aims to build on the success we have had in developing existing HIPC data standards, which have streamlined usage of data repositories such as ImmPort and ImmuneSpace, thereby benefitting the wider scientific community.